Composition and structure of antibody receptors at the surface of primary human cells during immune activation

Project Summary/Abstract
Fc g receptors (FcgRs) trigger cell-mediated cytotoxic mechanisms following interactions with
immunoglobulin G molecules clustered on the surface of a target molecule, protecting the host. Extensive post-
translational modifications (PTMs) on both the FcgRs and IgG are required for this interaction, including
asparagine-linked glycosylation (N-glycans). IgG N-glycans vary in response to stress and disease and
compositional variability of the N-glycan can modify the affinity for FcgRIIIa (CD16a) by as much as 8-fold in
vitro. FcgRs are more heavily modified than IgG with 2-7 N-glycans as well as a handful of other known
modifications, and the Barb lab demonstrated that CD16a N-glycan composition impacts affinity by as much as
100-fold. Thus, FcgR N-glycans impact affinity more than the IgG N-glycans. However, almost nothing is
known regarding FcgR composition within the human body, how composition changes in response to stress, or
how composition impacts the structure and function of the effector cell itself (excluding preliminary descriptions
of CD16a and CD16b). The successful completion of the experiments outlined in this proposal will provide
unprecedented detail regarding the modification of FcgRs and how these modifications impact function of the
immune system. These results will also emphasize the importance of defining PTMs from endogenous tissue
for functional studies as well as provide techniques to overcome common barriers that limit studies of
endogenous receptors.
In Aim 1.1, we will define the composition of FcgR PTMs, including: CD16a from macrophages, CD32a
from neutrophils, monocytes, macrophages, platelets and basophils; CD32b from B cells and basophils; and
CD64 from monocytes and macrophages. In Aim 1.2, we will isolate NK cells and monocytes from patients with
sickle cell anemia, myasthenia gravis and neuromyelitis optica to measure the cytotoxicity of these cells and
define the composition of CD16a and CD64. In Aim 2, we will characterize the structure of the immune
synapse and the locations of specific receptors and co-receptors, the kinetics of cell killing, as well as the
kinetics of synapse formation and receptor motion using NK cells and monocytes from the patients. These
results will be compared to the characterization of PTMs on the cells completed in Aim 1. Aim 2 will also study
how specific FcgR PTMs impact immune cell function using cultured cells. Multiple sources of data from both
Aims will be collected using samples from a single donor to identify variability in the donor population. By
comparing the large amount of data collected, we expect to identify specific features of PTM composition that
impact immune cell function and that represent novel therapeutic targets.

Public health relevance
Project Narrative This proposal will collect a wide range of observations using human tissue and a class of receptors purified from human tissue that function in the immune system to fight infection. We will compare tissue from healthy donors and from patients with sickle cell disease, neuromyelitis optica, and myasthenia gravis. Preliminary data indicates a wide variety of modifications may impact receptor, and thus immune, function.